Prostate Cancer

PROJECT SUMMARY
Cancer of the prostate is an extraordinarily common malignancy that exhibits substantial heterogeneity in its
clinical behavior, ranging from indolent, slow-growing tumors to aggressive tumors that rapidly progress toward
cancer-specific lethality. The Prostate Cancer (PC) Program promotes a multi-disciplinary research environment
designed to integrate basic sciences, population sciences, and clinical medicine to produce novel prevention
and therapeutic strategies that will positively impact human health. The program aims to advance and exploit
scientific knowledge that will reduce the morbidity and mortality attributed to prostate cancer and lead to
improvements in patients’ quality of life. The PC Program has three primary areas of focus where cooperative
efforts (allocation of resources; faculty recruitments; scientific collaborations) are coordinated to make
substantive advancements: 1) To develop approaches for determining early stage prostate cancer risk, optimize
detection strategies, and deploy risk-based interventions; 2) Develop a molecular understanding of the androgen
receptor signaling program to inform the rational design of therapeutic strategies for treating high-risk localized
and metastatic prostate cancer; 3) Develop therapeutic approaches for the treatment of prostate cancers directed
toward inhibiting key oncogenic (intrinsic) drivers, and modulating components of the tumor microenvironment.
The P30 CCSG supports this research program by providing: key shared resources, particularly Comparative
Medicine, Specimen Processing, Genomics, and Research Pathology; administrative and logistical support for
meetings, pilot funding for new clinical and translational research projects, and recruitment resources for new
faculty. The program currently has 43 members based at the University of Washington (UW) and the Fred
Hutchinson Cancer Center (FH), all of whom practice clinically at the UW, FH, and Veterans Administration Puget
Sound Health Care System. Ten members have primary appointments at FH, with 33 members at UW with
faculty appointments spanning 11 departments or divisions. Seven members joined this program since the last
cycle. Thirty-four members (77%) have peer-reviewed funding, are the principal investigator of a clinical trial or
are newly recruited and supported by the institution. The current research support of Program members
comprises $11.4M in peer-reviewed funding of which $6.5M (57%) is from the NCI. Due to the efforts in promoting
interdisciplinary studies, a substantial component of the research funding is in the form of P50, P01, and other
collaborative grants. Program members published 833 papers in the current cycle, of which 27% were
intraprogrammatic and 23% were interprogrammatic.